High Content Functional Neuroanatomy of Endogenous GPCRs

Abstract
G protein coupled receptors (GPCRs) modulate neuronal excitability and neurotransmitter release, and exert
profound effects on neural circuit functions. They play important roles in regulating motivation, reward, pain,
negative affect, and stress responses, which are all important in the context of substance use disorders
(SUDs). Exogenous ligands for several GPCRs have been shown to modify drug seeking behavior, which has
generated interest in GPCRs as targets for the development of pharmacological therapeutics for substance
use disorders. There are over 300 different non-sensory GPCRs expressed in mammalian brains, and
fundamental questions remain unanswered for all of them. For example, how does a given receptor's ability to
activate different G protein subtypes (Gi/o, Gs, Gq, G12/13) vary across neuroanatomical regions, cell types,
and subcellular regions? How are these properties altered in response to chronic drug use, chronic stress, or
chronic pain? To help answer these questions, we will develop new imaging methods in tissue sections for
neuroanatomical measurement of GPCR-mediated G protein activation, with subcellular resolution and G
protein subtype specificity. Our methods will only require common neuroscience equipment (cryostats and
fluorescence microscopes) and commercially available reagents. They will generate high-content information
on many GPCRs in healthy and diseased brains, and accelerate efforts to target GPCRs in addiction.

Public health relevance
Project Narrative We will develop new high-resolution anatomical imaging methods that provide detailed biochemical information on G protein coupled receptor (GPCR) signaling in the brain. The methods will be useful for measuring changes in GPCR function that occur in response to chronic drug taking, chronic stress, or chronic pain. They will enable new discoveries that can accelerate the development of pharmacological interventions for substance use disorders.